Role of matriptase in corneal epithelial homeostasis and repair

Project summary/Abstract: The role of the corneal epithelium is to: 1) act as a barrier against physical trauma,
pathogens, and chemicals, 2) maintain a constant level of stromal hydration, and 3) serve as an optical interface
focusing light onto the retina with optimal quality. A healthy corneal epithelium requires coordinated actions of
multiple dynamic cellular processes and signaling pathways. To date, studies of extra- and pericellular proteases
in eye and vision research have mostly centered on their harmful effects in corneal wound healing and infection.
Based on our preliminary data, we hypothesize that the cell-surface anchored serine protease matriptase, in
contrast, is essential for normal ocular surface function and promotes recovery from injury to the corneal
epithelium. We generated matriptase hypomorphic mice and observed an abnormal irregular corneal surface cell
pattern and increased inflammation. Our preliminary data using human corneal epithelial cells suggest that
matriptase silencing causes decreased barrier function accompanied by impaired tight junction (TJ) integrity and
aberrant proteolytic processing of the epithelial cell adhesion molecule (EpCAM). Under injury conditions, we
identified the pro-form of hepatocyte growth factor (pro-HGF) as a candidate substrate for matriptase with key
functions in corneal wound healing. Matriptase efficiently cleaves pro-HGF and converts it into the active form
needed for activation of its cell-surface tyrosine kinase receptor c-Met and for subsequent stimulation of cell
migration. Our hypothesis is that matriptase promotes corneal epithelial barrier function via regulation of tight
junction formation and promotes tissue repair by activation of the HGF/c-Met signaling pathway.
Aim 1: Determine the role of matriptase in corneal epithelial maintenance and function. Novel matriptase
knockout mouse models as well as 3D cellular models of the human cornea will be utilized. We will use a
balanced combination of hypothesis-driven targeted experimentation and unbiased approaches to
comprehensively characterize the role of matriptase in corneal homeostasis and to identify critical pathways
required for proper regeneration and differentiation, TJ formation, EpCAM processing, and barrier function.
Aim 2: Identify functions for matriptase in corneal epithelial tissue repair. Matriptase-deletion mouse
models and 3D epithelium/stroma cell models will be used to determine the impact of matriptase on corneal
repair in experimental wound repair. Comparative RNA-Seq and Mass Spectrometry analysis will be performed
to identify matriptase substrates and matriptase-mediated pathways in homeostasis and injury response. The
impact of stimulation with Internalin B321 (
InlB321
),
an agonist of the HGF receptor c-Met,
on cell migration/tissue
repair in vitro and in vivo will be tested as a potential therapeutic strategy to treat corneal epithelial injury.
Significance: Implementation of the approaches described in this proposal will provide a mechanistic
understanding of the role of matriptase in corneal epithelial homeostasis and injury and identify actionable targets
(factors/pathways) for therapeutic options to promote corneal epithelial repair leading to restoration of function.

Public health relevance
Project narrative Injuries or diseases involving the cornea, the protective outer layer of the eye, can lead to infection, inflammation, and vision impairment which greatly affect the quality of life for patients. The key objective of the current project is to identify the molecular and cellular mechanisms that ensure maintenance of a healthy and functional cornea, as well as the natural processes that facilitate corneal self-repair. This knowledge will be used to develop new treatments for patients with corneal injury and/or disease.